Human iPSC Model to Elucidate Metabolic Interplay in Diabetic Cardimyopathy

Project Summary
Type 2 diabetes (T2D) is a leading cause of death nationwide with 65% of mortality due to cardiovascular
disease. The term “diabetic cardiomyopathy (T2DCM)” refers to a condition with adverse myocardial structural
changes, in the absence of hypertension and vascular pathology. Although T2D and CVD are tightly intertwined,
we lack a deeper understanding of T2DCM at the molecular and cellular levels. In recent years, sodium-glucose
cotransporter-2 (SGLT2) inhibitors have emerged as a promising therapeutic for T2DCM, but the precise
protective mechanisms in cardiomyocytes, fibroblasts, and endothelial cells which construct the cardiac
microenvironment remain incompletely understood. In this multi-PI R01 renewal, our team will elucidate the
mechanisms of metabolic interplay within and between cardiovascular cells which confer cardiac protection by
SGLT2 inhibition. We will harness induced pluripotent stem cell (iPSC) technology to generate diabetic models
of cardiovascular cell types for cellular and metabolic phenotyping of SGLT2 inhibition in vitro (Aim 1). We will
construct iPSC-derived engineered heart tissues for functional phenotyping and proteomic determination of the
SGLT2 inhibitor protein interactome (Aim 2). Afterward, we will validate cardioprotective mechanisms in a
diabetic mouse model at single-cell resolution (Aim 3). In summary, understanding the exact role and mechanism
of SGLT2 inhibition in T2DCM may contribute to finding new therapeutic modalities for the treatment of metabolic
heart diseases.

Public health relevance
Project Narrative Diabetic cardiomyopathies (T2DCM) are a leading cause of death nationwide and understanding metabolic interplay in the heart is crucial for the development of new therapies. Our research team will use human induced pluripotent stem cells (iPSCs) to generate cardiovascular cell types for in vitro modeling of T2DCM for the determination of altered metabolic pathways, functional phenotyping, and protein targets. Then, we will analyze diabetic mouse hearts to validate cardiac protective mechanisms at single-cell resolution.